Substrate targeting mechanism of a DesCEND pathway

Project Summary
Ubiquitin-mediated protein degradation is essential to maintaining proteostasis, thereby controlling diverse
cellular processes. The specificity of protein ubiquitination is largely determined by recognition of short peptide
motifs known as degrons in protein substrates by E3 ubiquitin ligases. F-box proteins serve as substrate-
recognition components of the Skp1–Cul1–F-box-protein (SCF) E3 superfamily. The F-box protein FBXO31
mediates cyclin D1 degradation to induce G1 arrest after DNA damage. The C-terminal region of cyclin D1
contains sequences rich in Pro, Glu/Asp, Ser and Thr. This so-called PEST motif is enriched in highly dynamic
disordered regions of eukaryotic proteins and serves as degradation signal for many unstable proteins. We have
recently determined the X-ray crystal structure of a C-terminal PEST-containing cyclin D1 peptide bound to
Skp1–FBXO31. The structure reveals that specific recognition is achieved by an intricate inter-molecular
interaction network involving as well the cyclin D1 carboxyl tail that occupies an open surface cavity in the -
barrel motif of FBXO31. We show that this PEST degron mediates the interaction of cyclin D1 with FBXO31 for
ubiquitination in vitro and proteolysis in cells. We hypothesize that FBXO31 is responsible for recognition of C-
terminal PEST-containing substrate degrons through a novel DesCEND (destruction via C-end degrons)
pathway. By identifying and characterizing substrates of FBXO31 at both a systems level and the molecular
level, we aim to elucidate the complementary structural determinants of the FBXO31–degron pair that confer
substrate specificity and dictate protein recognition and fate. To achieve our goals, we have developed the
following specific aims to: 1) identify and characterize C-end substrate degrons targeted by FBXO31 in human
proteins; 2) characterize the structural and biochemical properties of candidate FBXO31 degrons; and 3)
characterize endoproteolytic cleavage-generated FBXO31 degrons.

Public health relevance
Project Narrative Human protein ubiquitin ligases play critical roles in cellular proteostasis and pathogenesis by targeting broad substrate networks for proteasomal degradation. The research plan outlined here will investigate the substrate targeting mechanisms of the F-box subunit FBXO31 of the SCF ubiquitin ligase in a novel DesCEND pathway and ultimately address the therapeutic potential of FBXO31 as a drug target.